AAMC Career Development Program for MOSAIC Scholars

Project Summary/Abstract:
The Association of American Medical Colleges (AAMC) is committed to increasing the diversity,
equity, and inclusion of the biomedical research workforce and will develop a multichannel
educational program for cohorts of NIH-awarded K99/R00 scholars from groups
underrepresented in research as they transition from postdoctoral appointments into academic
research faculty positions to help advance this goal. The AAMC will richly and robustly engage
the scholars in a curriculum throughout all award years that includes skills-building workshop
participation, immersive activities with their local institutional and AAMC-identified mentors, and
leadership and professional development conference attendance with field experts and peers
nationwide. Components of the program include: 1) Matching each scholar with an academic
mentor identified by the AAMC; 2) Partnering with the National Research Mentoring Network
(NRMN) to create an exclusive environment where scholars and mentors can engage in
culturally responsive mentorship; 3) Delivering skill-building workshops, including partnering
with the Center for the Improvement of Mentored Experiences in Research (CIMER) to deliver
mentoring content, and designing intersession work to prepare scholars for their transition to
faculty positions and to thrive as faculty members; 4) Offering participation in AAMC leadership
and professional development conferences that feature speakers who are successful leaders in
academic medicine and science, and include ample opportunity to meet and network with other
conference participants from the nation’s medical schools and teaching hospitals; and 5)
Organizing networking and learning events for scholars from all active cohorts to visit a AAMC-
member institution, engage in peer mentoring, hear from leaders in the field, and learn about
leadership topics not covered in the core skill-building workshops. The AAMC will utilize its vast
network of diverse faculty and leadership—across disciplines, medical specialties, and types of
graduate degrees (MD, MD-PhD, and PhD)—to identify mentors, faculty, and advisory
committee members. Formative and summative evaluations will be utilized to determine
whether the project effectively and efficiently advances the overall program goal to enhance the
diversity of the biomedical research workforce by supporting individuals underrepresented in the
field. We are also firmly committed to broad dissemination of implementation results. The AAMC
is ideally positioned for program success—and has the resources, expertise, and reach to
properly execute, assess, and promote wider scaling of this endeavor.

Public health relevance
Project Narrative: The Association of American Medical Colleges (AAMC) welcomes the opportunity to partner with the National Institutes of Health (NIH) National Institute of General Medical Sciences (NIGMS) to advance our shared goal of enhancing the diversity of the biomedical research workforce. Through this funding opportunity, the AAMC will develop and deliver a multichannel educational program for cohorts of NIH-awarded K99/R00 scholars from groups underrepresented in research that provides a full suite of career development tools and supports as they transition from postdoctoral appointments into academic research faculty positions. The AAMC will richly and robustly engage the scholars in a curriculum throughout all award years that includes skills-building workshop participation, immersive activities with their local institutional and AAMC-identified mentors, and leadership and professional development conference attendance with field experts and peers nationwide.